FUTURE DIRECTIONS FOR APPLYING BEHAVIORAL ECONOMICS TO POLICY

The office of OBSSR work with National Academy of Science in organizing meetings and publications pertaining to the studies on behavioral economics.

Public health relevance
Public Health Relevance: